IMMUNOHISTOCHEMICAL STUDY OF SKIN BIOPSY SAMPLES FROM VITILIGO PATIENTS

The purpose of this study is to determine the correlative importance of the tyrosinase autoantibodies to the skin lesions of vitiligo patients studied by immunohistochemical methods.